The Role of Lung Megakaryocytes in Airway Disease after Neonatal Hyperoxia

Former preterm infants are exposed to oxygen (O2) after birth which results in long-term developmental
impacts on the lung. Approximately 70% of infants born extremely prematurely (<29 weeks’ gestational age) will
have increased pulmonary morbidity and/or early childhood wheezing disorders even though many are not
diagnosed with Bronchopulmonary Dysplasia (BPD). These infants are especially vulnerable to airway
hyperreactivity (AHR) after respiratory viral infections through poorly understood mechanisms. Herein, we utilize
a low-dose hyperoxia mouse model and a unique pediatric human tissue repository grounded on a new discovery
that neonatal O2 increases the abundance of lung megakaryocytes (MKs), an understudied myeloid cell biased
toward immunomodulatory functions. After respiratory viral infection, lung MKs release profibrotic cytokines such
as Thrombospondin-1 (TSP-1), a critical inflammatory regulator and activator of transforming growth factor beta
1 (TGFβ1) that drives fibrosis. We hypothesize that neonatal hyperoxia primes the lung for AHR by increasing
the recruitment of lung MKs and predisposing MKs to release pro-fibrotic factors (e.g. TSP-1) after infection. Aim
1 will determine how the hyperoxic lung environment after birth effects lung MK recruitment and seeding including
how O2 at different developmental ages and MK depletion affect the lung MK population. Aim 2 will determine
how neonatal hyperoxia effects lung MK transcriptome before and after activation using in vitro cytokine assays
and RNAseq. Experiments will also determine if AHR is MK or TSP-1 dependent by comparing Influenza
infection models of MK-depleted mice to transgenic mice with the TSP-1 gene deleted from MKs. Aim 3 will
determine how neonatal O2 effects the bone marrow MK pool, including its effects on platelet production.
This proposal is a five-year mentored research award and training plan for Dr. Andrew Dylag, MD to
investigate oxygen-induced mechanisms of airway dysfunction in both mice and procured human tissues. Dr.
Dylag is an Assistant Professor of Pediatrics (Neonatology) at the University of Rochester Medical Center. The
research herein builds on Dr. Dylag’s experience as a clinical neonatologist and a basic scientist interested in
O2 injury and post-hyperoxia airway hyperreactivity (AHR). As part of his career development plan, Dr. Dylag will
attain expertise through four (4) career aims: 1) Increase knowledge and technical skills in the investigation of
lung development and repair after injury using translational in vivo models, 2) Targeted training in bioinformatics
analysis including transcriptomics, 3) Develop expertise in applying in vivo laboratory discoveries to human
tissues and clinical human disease, and 4) Develop the necessary skills to lead an effective translational research
program. Dr. Dylag will attain his stated goals by applying new skills in flow cytometry, immunohistochemistry,
transcriptomics, and targeted bioinformatics training to a mouse and human tissues. At the completion of this
career development award, Dr. Dylag will have interrogated one mechanistic role of how early life O2 drives AHR,
advancing our understanding of how neonatal O2 exposures drive longer-term pulmonary morbidity.

Public health relevance
PROJECT NARRATIVE The incidence of premature birth (delivery more than three weeks early) is increasing worldwide and many infants born extremely preterm (less than 28 weeks' gestation) suffer long-term lung disease resulting from injury due to oxygen therapy and mechanical ventilation. These former preterm infants experience lifelong breathing problems, including wheezing and increased respiratory infection severity which puts a high burden on the health care system because of the need for continued care and rehospitalization. This project will contribute to our understanding of reasons why preterm infants and their oxygen exposures at birth leave them vulnerable to worse respiratory infections and wheezing later in life, in attempts to alleviate this burden.